MOASIC: Mobile lung Screening evaluation and outComes

Background: Lung cancer kills more Veterans annually than the next three cancers combined. Lung cancer
screening (LCS) with low-dose CT reduces lung cancer mortality through early detection, yet only 2.8% of
eligible Veterans have been screened. The Lung Precision Oncology Program (LPOP) was developed to
expand the availability of high quality LCS across the VA enterprise. Through our work done through a QUERI
Rapid Project Proposal and that of others, drive time distance to a VA CT scanner has been shown to be a
barrier to LCS, especially for rural Veterans. VISNs 7 and 9 will be implementing mobile LCS (mLCS) to
address this known barrier. We hypothesize that mLCS will increase LCS reach including 1) the proportion of
Veterans offered LCS by providers, 2) uptake of LCS among eligible Veterans, and 3) adherence to
recommended follow-up LCS among Veterans utilizing mLCS. Significance: This evaluation will determine the
impact of mLCS on the offering, acceptance, and adherence to LCS by eligible Veterans. Identify facilitators
and barriers to mLCS implementation and determine start up, maintenance and overall cost efficacy.
Innovation & Impact: The evaluation of implementation of mLCS in the Veterans Health Administration (VHA)
is innovative and will inform mLCS implementation for other VHA sites and beyond VHA. Understanding
provider and Veteran perceptions of mLCS, barriers and facilitators to implementation, estimates of Veteran
demand, and best technology practices will provide valuable information to be included in a checklist for
replication and implementation across VHA. Ultimately this will impact and ensure mortality reduction of lung
cancer through early detection. Specific Aims: 1. Pre-implementation: Understand the development of mLCS,
assess provider staff perceptions, anticipated barriers and facilitators to implementation, and engage Veterans
to optimize implementation and messaging.2. Implementation Outcomes: Conduct a mixed-methods evaluation
of the reach (offering, uptake, and adherence) and acceptability of mLCS implementation. 3. Clinical/Health
Outcomes: Evaluate the clinical impact of and satisfaction with mLCS on the offering of, acceptance by, and
adherence to LCS by eligible Veterans. 4. Economic impacts: Assess start-up and continuing costs of mLCS
programs including implementation support costs and compare cost of mLCS compared to traditional care and
community care. Methodology: A mixed methods approach to the planning, delivery and evaluation (formative
and summative) of mLCS implementation is proposed. The Reach, Effectiveness, Adoption, Implementation,
Maintenance (RE-AIM) Framework will be used for planning and summative evaluation. In addition, the
Practical Robust Implementation and Sustainability Model (PRISM) will be utilized for formative evaluation at
each Community-Based Outpatient Clinic (CBOC) location utilizing mLCS. Data will be collected through
quantitative and qualitative assessments including surveys and interviews of providers/staff and the corporate
data warehouse. Change in proportion of eligible Veterans offered, accepting, and adherent to LCS prior to
and after implementation of mLCS. Results will be characterized for the overall cohort of Veterans pursuing
mLCS and stratified by distance traveled for screening. Next Steps/Implementation: Our research team will
partner with key stakeholders to create a checklist of resources needed and steps to take to gain support, fund,
and implement mLCS that will serve to assist other VA VISNs and facilities considering mLCS. We will partner
with Veteran stakeholders to identify the best way to message mLCS to optimize implementation.

Public health relevance
Lung cancer is responsible for more death in the United States than breast, prostate and colon cancer combined and is the number one cancer killer in veterans. This is because lung cancer is usually diagnosed when the disease has spread and cure is less likely. Screening for lung cancer with a scan finds cancer at an earlier stage when it is curable. Screening for lung cancer is recommended for people that are at high risk based on age and smoking history every year. Unfortunately, many people eligible for screening have not been screened and one reason is the distance needed to travel to a place offering it. The proposed study will evaluate the implementation of mobile lung cancer screening to understand facilitators and barriers and determine the impact of mobile lung cancer screening on offering, uptake and return for annual lung cancer screening.